ESTABLISHMENT/MAINTENANCE OF BIOMEDICAL RESEARCH COLONY

(Adapted from the applicant's abstract): This cooperative agreement combines the strengths of two previously funded, highly successful programs for chimpanzee care breeding, and research; The UT M.D. Anderson Cancer Center (UT-MDACC), Department of Veterinary Sciences in Bastrop (DVSB) and the PFA in Mesa. Through a subcontract with PFA and the addition of new housing facilities at DVSB, the investigators can significantly increase the number of chimpanzees under an experienced, coordinated veterinary care, management, and research program. They have a detailed Memorandum of Understanding with PFA to perform for them as a subcontractor. By incorporating PFA into the research-oriented mission of DVSB, they can significantly increase the likelihood of satisfying the proposed need for a stable long-term national resource of chimpanzees for biomedical research. This application will dedicate 186 of the most demographically balanced, physically and behaviorally healthy chimpanzees in the country to the management of an internationally recognized research institution. This dedicated colony will serve as a Core resource to support peer-reviewed investigations requiring the chimpanzee model. When appropriate, the investigators will be charged for using these chimpanzees. In addition to having biohazard and conventional holding facilities for all age chimpanzees, the DVSB can provide an array of molecular, viral, immunological, anatomical and clinical pathology research services. Increasing investigator awareness of the availability of chimpanzees, appropriate investigative housing and sophisticated research support capabilities of DVSB should enhance the prudent investigative use of the chimpanzee. The investigators proposed new biomedical research and housing facilities that will support an additional 100-175 chimpanzees. The proposed design maximizes flexibility and options for housing individuals and small or large groups. The current and new facilities will provide a balance between an enriched and a protected habitat. To complement the facilities, they have sufficient numbers of dedicated and experienced professional and technical personnel. All of their objectives can be accomplished in a manner meeting societal expectations for the humane care and use of chimpanzees. They will continue to perform clinical investigations to improve chimpanzee health, genetics, management and well-being. Positive reinforcement training techniques will be refined to increase voluntary cooperation of chimpanzees with numerous research and investigative procedures. The proposed plan and facilities have a 20-year track record to substantiate their success in cost- effective delivery of high quality husbandry, care, and research with the chimpanzee.